Roles for Claudin11 in Regulating Endothelial Barrier Function

PROJECT SUMMARY
According to the CDC, approximately 1.7 million people in America develop sepsis, an uncontrolled bacterial
infection, each year where the financial burden is estimated to be $62 billion annually in hospitalizations and
nursing care. Sepsis is a global threat with no specific treatment options. A key feature of sepsis is the breakdown
of endothelial cell barrier function. Endothelial cells line blood vessels and act as the primary barrier for
exchange of fluid, waste, and nutrients between the blood and tissue. Baseline permeability of the endothelial
barrier is vessel dependent, where permeability is low in arterioles and high in post-capillary venules. Endothelial
barrier permeability is regulated through the apical junctional complex composed primarily of tight junctions and
adherens junctions. Tight junction proteins, specifically claudins, directly regulate permeability of the endothelial
barrier where claudin11 is expressed in a venous specific manner, making it a focus of this study. Maintenance
of vascular homeostasis is important in preventing the pathologic consequences of disease, including sepsis,
which occurs from a dysregulated inflammatory response to infection. This dysregulated immune response
induces changes in endothelial barrier function making the molecular mechanisms underlying endothelial barrier
function crucial for development of novel therapeutics. Recent work has demonstrated that TNF, a contributing
factor to inflammation in sepsis, causes a defect in venous endothelial barrier function that is mediated through
a pannexin1-dependent pathway. The central hypothesis of this proposal is that the tight junction protein
cldn11 forms a signaling hub with pannexin1 that regulates barrier function in response to inflammation.
I will test this hypothesis in two aims: Aim 1 will investigate protein composition changes in response to pro-
inflammatory cytokines using BioID; Aim 2 will examine changes in vessel permeability in response to pro-
inflammatory cytokines measured by changes in transendothelial resistance, immunoblot, and
immunofluorescence. A long-term goal of this project is to identify potential therapeutic targets that promote
endothelial cell barrier function that would otherwise be compromised as a result of inflammation and sepsis.

Public health relevance
PROJECT NARRATIVE Sepsis is a serious uncontrolled bacterial infection with high mortality rates, making it a significant health concern. The endothelium, a single layer forming a barrier that lines blood vessels and arteries and regulates exchanges between the bloodstream and surrounding tissues, is compromised in patients with sepsis. This project is focused on better understanding the molecular mechanisms that control the endothelial cell barrier at baseline; how those molecular mechanisms change in response to inflammation; and identify approaches to target endothelial cell barrier function as a therapeutic approach to strengthen weakened endothelial cells in sepsis patients.